Role of CREG1 in metabolic homeostasis

Project Summary
Type 2 diabetes mellitus (T2DM) is caused by insulin resistance and reduced insulin secretion. Cellular
repressor of E1A-stimulated genes 1 (CREG1), a small glycoprotein involved in membrane trafficking in the
endocytic and secretory pathways, may be involved in the pathogenesis of T2DM, as suggested by the insulin
resistance, glucose intolerance, elevated glycemia and hypoinsulinemia in whole-body Creg1 knockout mice.
Gain- and loss-of-function studies using cultured hepatocytes and liver-specific Creg1 knockout mice
demonstrate that CREG1 autonomously regulates cellular insulin signaling, insulin sensitivity, and the expression
of insulin receptor on the plasma membrane. In pancreatic β-cell-specific Creg1 knockout islets, increased
proinsulin and diminished insulin levels lead to impaired insulin secretion. Furthermore, CREG1 expression is
nutritionally regulated and is progressively downregulated by high-fat diet consumption. This project will test (1)
whether loss of CREG1 inhibits insulin receptor recycling and consequently impairs insulin signaling and insulin
action, (2) to what degree CREG1 downregulation contributes to insulin resistance in metabolic disease, and (3)
whether Creg1 ablation impedes insulin granule trafficking and enhances insulin degradation. In the first Aim,
we will delineate the role of CREG1 in the regulation of insulin receptor trafficking and its contribution to hepatic
insulin action and cellular insulin signaling. We will restore CREG1 expression in high fat diet fed mice via adeno-
associated virus-mediated CREG1 gene delivery and test if this improves insulin sensitivity and insulin signaling.
In the second Aim, we will elucidate how loss of CREG1 leads to reduced β-cell insulin content with a focus on
proinsulin processing and insulin degradation. Pulse-chase labeling and live cell imaging, electron microscopy,
and biochemical analysis combined with complex physiological study protocols will be used in the proposed
studies. Our long-term goals are to elucidate how CREG1 regulates hepatic insulin action and β-cell insulin
secretion, and to target CREG1 to treat T2DM.

Public health relevance
Project Narrative Type 2 diabetes is caused by insulin resistance and impaired insulin secretion. Elucidating the mechanisms by which CREG1 regulates insulin secretion and action is critical to understanding the pathogenesis of type 2 diabetes and the development of new therapeutic interventions to curb its epidemic.